COG NCTN Network Group Operations Center Year 11 Extension

PROJECT SUMMARY
Since the introduction of chemotherapy for the treatment of childhood leukemia more than 60 years ago, the
prognosis of childhood cancer has improved dramatically. The overall 5-year survival rate for childhood cancers,
many of which were uniformly fatal in the pre-chemotherapy era, is now 86%. Progress for a number of childhood
cancers, however, has been limited, with approximately 50% of children with acute myelogenous leukemia, 50%
of children with high-risk neuroblastoma, and more than 90% of children with brainstem glioma, still succumbing
to their disease. In the US, cancer remains the leading cause of death from disease in children greater than one
year of age. Moreover, the late effects of cancer treatment, including permanent organ and tissue damage,
hormonal and reproductive dysfunction and second cancers, are of special concern, with more than 40% of the
500,000 survivors of childhood cancer (estimated as of 2020) experiencing a significant health related quality of
life complication from childhood cancer and its treatment. Thus, despite our advances, development of new
therapeutic approaches must be a priority for childhood cancer basic, translational, and clinical researchers.
The Children’s Oncology Group (COG), the world’s largest organization devoted exclusively to childhood and
adolescent cancer research, was founded 24 years ago. The COG’s multidisciplinary research team, comprised
of more than 12,000 members, conducts research at more than 220 leading children’s hospitals, universities,
and cancer centers. This proposal is for COG, as part of the National Cancer Institute’s (NCI) National Clinical
Trials Network (NCTN), to continue its collaborative research work that supports the mission of improving the
outcome for all children with cancer. The COG will design and conduct clinical-translational studies for children
with cancer that build on an increasing understanding of the molecular basis for pediatric malignancies and
which have the highest potential to improve outcomes. Using innovative clinical trial designs suitable for
the study of rare diseases, we will study novel therapeutic approaches including but not limited to
targeted small molecule drugs, immunotherapies, and cellular therapies. The COG research portfolio
importantly also includes clinical trials focused on improving the quality of life for children with cancer and
childhood cancer survivors. As more than 80% of children diagnosed with cancer in the US are treated at
COG member institutions, COG has the ability to offer a diverse population of children with cancer and their
families the opportunity to participate in innovative research. This research effort includes collecting and
annotating biospecimens from all children with cancer, providing the foundation for discovery and accelerating
the most promising research efforts conducted in laboratories around the world. The proposal is for support of
the COG Network Operations Center, clinician- scientists who develop and conduct research, and for member
sites to participate through enrollment of eligible subjects.

Public health relevance
PROJECT NARRATIVE The Children’s Oncology Group (COG) is the world’s largest organization devoted exclusively to childhood and adolescent cancer research. Over 220 leading children’s hospitals, universities, and cancer centers across US, Canada and other countries participate in COG research, which is focused on developing better treatments that can improve the cure rate and outcomes for all children with cancer.